CE25-029 - The Role of Longitudinal Community Resilience in Youth Violence Across Racial Groups: Impact of Childhood Abuse and Neglect

PROJECT SUMMARY: Fei Pei, PhD, MSW, is a social scientist whose overarching career goal
is to identify the complex effects of community resilient factors on child abuse and neglect and
youth violence and to develop effective interventions/preventions that address these issues.
This CDC career award will provide Dr. Pei with rigorous training and systematic mentored
research experiences to support her transition to an independent investigator in youth violence
prevention and intervention. A team of prominent mentors will guide her proposed research
aims and training activities. The career development plan includes four hands-on training goals
to strengthen her expertise in: understanding community resilience and interventions for
vulnerable youth (Goal 1), exploring youth violence across racial groups (Goal 2), mastering
ethnographic methods (Goal 3), and applying advanced longitudinal statistics (Goal 4). During
the award period, Dr. Pei will apply these new skills and knowledge to investigate the complex
associations among community resilience, child abuse, neglect, and youth violence across
racial groups. Community resilience encompasses various domains, including violence,
physical environments, social relationships, and economic status. A community may exhibit
resilience in certain domains while lacking in others, and these domains can interact in
complex ways that influence youth violence. Additionally, community environments can vary
among different racial groups, yet empirical studies rarely explore how community resilience
differs across youth from different racial groups. Therefore, it is crucial to understand how the
profiles of community resilience influence youth violence across racial groups, which can
further foster the achievement of the American ideals of a pluralist society in the next
generation. This proposed study aims to: 1) identify how profiles of community resilience
influence youth violence across racial groups; 2) estimate the mediating effects of child abuse
and neglect on the relationship between community resilience profiles and youth violence; and
3) explore the challenges and gaps in current interventions for youth with violent behaviors
from a community resilience perspective. This study will contribute empirical evidence on the
relationship between community resilience and youth violence, enabling intervention scientists
to consider community-level factors when working with adolescents at higher risk for violence.

Public health relevance
PROJECT NARRATIVE: Child abuse, neglect, and youth violence are highly-prevalent and tightly-connected public health issues in the United States. This study aims to use both quantitative and qualitative methods to identify distinct profiles of community resilience, track their longitudinal changes across racial groups, and evaluate their role in predicting youth violence, with child abuse and neglect as mediating factors. This research is critical to population dynamics, as it will enable intervention scientists to consider and incorporate community-level factors when working with adolescents at risk for violent behaviors.